Testing Approaches to Promote Breast Cancer Screening in Rural Ghana

Project Summary
Breast cancer (BC) is the most common cancer among women worldwide and has profound implications for
the well-being of women and their families. In sub-Saharan Africa, BC incidence is rising, late presentation is
common, younger women are disproportionately affected, and survival rates are low. One of the
Government of Ghana’s top strategies to combat BC is early detection through routine screening, yet
screening rates are low. Our multidisciplinary team has designed two interventions to surmount three key
sociocultural and economic barriers and increase the utilization of BC screening, including (1) time and
transportation costs, (2) cultural beliefs and stigma, and (3) male dominance in decision-making and lack of
social support for women. The BUNDLING intervention offers women BC and diabetes education followed
by BC and type II diabetes screenings during the same visit to the local clinic. Provision of simultaneous
(bundled) screenings is hypothesized to increase BC screening through several mechanisms, including
reducing time/transportation costs and diluting the stigma of seeking BC screening on its own. The MEGH
(Male Engagement in Gender and Health) Program offers BC education to women and their male partners,
invites partners to 7 weekly discussion group sessions (5 men-only and 2 women and men), and
subsequently offers women BC screening at the local clinic. The MEGH Program is hypothesized to increase
BC screening through several mechanisms, including changing men’s gender attitudes, increasing women’s
control over decision-making, and increasing men’s social support. Our long-term goal is to test the
effectiveness of these interventions in a future clustered RCT. The overall goal of the proposed R21 project
is to finalize the design and implementation aspects for the future RCT in a feasibility study. The specific
aims are: (1) Refine study materials (education materials, MEGH Program curriculum, data collection
instruments) for cultural relevance and implementation. We consult with an expert advisory committee and a
local committee in an iterative process. (2) Determine the feasibility of the two interventions using sequential
mixed methods. We assess the interventions in three clinic zones (2 interventions + a control) with women
age 20+ (and male partners in the MEGH group). We conduct baseline and endline surveys, followed by
qualitative in-depth interviews. (2A) Establish feasibility based on recruitment, retention, and acceptability.
(2B) Assess initial evidence of efficacy and intervention fidelity, and clarify these findings through
participants’ insights from follow-on in-depth interviews. We assess the strengths and weaknesses of the
interventions, challenges to intervention fidelity, and implementation approaches. (2C) Examine initial
evidence of the effect of interventions on the mechanisms, and clarify these findings through participants’
insights. (2D) Finalize the protocol for the future clustered RCT using study findings. These new
interventions tackle key barriers to improving a critical health behavior—BC screening—for women. The
study will generate a prototype for addressing the high incidence of BC in low-income settings.

Public health relevance
Project Narrative The proposed study will assess the feasibility of two novel interventions to tackle important sociocultural and economic barriers to the utilization of routine breast cancer screening by women. In doing so, this study will inform efforts to improve a critical health behavior for women and generate a prototype for addressing the high incidence of breast cancer in low-income settings.